NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens

PAR-20-124, NARMS Cooperative Agreement Program to
Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens (U01)
MD Department of Health, 2020
ABSTRACT
Foodborne bacterial infections have contributed to morbidity and mortality world-wide. To track
antimicrobial resistance in enteric bacteria isolated from retails meat products, National
Antimicrobial Resistance Monitoring System (NARMS) was established to perform public
health surveillance in the United States. The Maryland Department of Health (MDH) has been a
partner with the NARMS program for numbers of years and has been successfully contributing
to the data development used in the bacterial illness and antimicrobial resistance studies. At
MDH, the project has been performed in collaboration between MDH epidemiologists and MDH
laboratory scientists to assure the quality of the data. Retail meats including ground beef, ground
turkey, pork, chicken and seafoods are purchased from stores across the State of Maryland and
processed according to the protocols established by the NARMS program. The target organisms
from the retail meats include Salmonella, E. coli and Enterococci and Campylobacter whereas
Vibrio, Aeromonas, Enterococcus and lactose fermenting bacteria are isolated from seafood
products. The isolate identification is confirmed with appropriate methods before submitted to
the FDA. Isolates including E. coli, Campylobacter and Salmonella are subjected to whole
genome sequencing and the data are submitted to the FDA. After all isolates are confirmed and
frozen, they are shipped to the FDA for antibiotic susceptibility testing and further
characterization.

Public health relevance
PAR-20-124, NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens (U01) MD Department of Health, 2020 PROJECT NARRATIVE Antibiotics have inexorably changed the landscape of public health as they play a significantly role in the treatment of infectious diseases. However, antimicrobial resistance caused by excessive or incorrect use of antibiotics has become one of the major public health issues. Foodborne pathogens can also develop resistance to certain antibiotics via the exposure of antimicrobials agents primarily from inappropriate use within agricultural practices, leading to circulation within our current food production system. These pathogens can also serve as reservoirs for antimicrobial mobile genetic elements that may transfer to other pathogens. As a result, the growing trend of antibiotic resistance of foodborne pathogens continues to elevate concerns of food safety within the United States. The main goal of the FDA NARMS cooperative agreement project with Maryland Department of Health is to isolate and characterize foodborne pathogens including Salmonella, Campylobacter sp., E. coli, Enterococcus sp., Vibrio sp., Aeromonas sp. from several retail food products purchased from stores across Maryland. After the pathogens have been isolated, they are subjected to downstream phenotypic and genotypic characterizations as well as whole genome sequencing. The isolates and data are submitted to the FDA monthly. The Maryland Department of Health, Laboratories Administration has the capability and capacity to implement the current project and future pilot projects using advanced technologies to further characterize these isolates including speciation, serotyping, and whole genome sequencing.